Administrative Supplement to Expand Enhancement of the IMHRD Cohort in EXACT-PLAN

TITLE: Administrative Supplement to Expand Enhancement of the IMHRD Cohort in EXACT-PLAN
ABSTRACT. The NIAMS funded parent project planning award entitled: “Enhancing the IMHRD cohort to support
study of the exposome in autoimmune disease” seeks to develop resources and strategies needed to examine
the role the exposome plays in the development and progression of autoimmune disease within a highly diverse
cohort centered on lupus and scleroderma. Achieving this goal will advance NIH’s EXposome in Autoimmune
Disease Collaborating Teams PLANning Awards (EXACT-PLAN) initiative by direct contributions to the
collaborations, resources, and methodologies necessary to conduct exposome-wide association studies
(ExWAS) that can comprehensively assess the role the environment plays in autoimmune disease. The goal of
this administrative supplement is to expand the parent grants infrastructure and resources to include emerging
directions and priorities identified through new collaborations with the Network for Exposomics in the United
States (NEXUS; U24ES036819), HERCULES Exposome Research Center (P30 ES019776), and the NIH
OADR/NLM. It is important to note that these directions are within the scope of the original award and directly
align with NOT-OD-23-112. This supplement is necessary to address the unforeseen costs associated with
achieving goals in three additional projects. The first includes support to develop workflows and resources
necessary to facilitate a multi-site geospatial project focused on establishing geographic resources needed to
characterize the external exposome for study populations within EXACT-PLAN. This project includes
participation from all EXACT-PLAN sites and incorporates extensions recommended by the Geospatial Sciences
Hub in NEXUS. The second project will enhance application of exposomics resources and expertise within
EXACT-PLAN by establishing a new collaboration with the HERCULES Exposome Research Center and
IMHRD. This includes support to access metabolomic, targeted analyses, and data science resources within
HERCULES. This supplemental project will build upon the PI’s HHEAR project by incorporate new directions
focused on the internal exposome. This will include targeted analyses of biological samples, assistance with
analyses of untargeted metabolomics data, and resources to enhance epigenetic research in IMHRD. The third
project seeks to establish the bioinformatics resources necessary for preparation of IMHRD resources to
participate in a Federated Data Platform. Successful completion of these supplemental projects has multiple
benefits as execution will enhance resources and decision-making tools needed to promote success of a future
EXACT Network. Secondly, findings will fill important knowledge gaps related to the burden and health impacts
of chemical and geographically determined exposures experienced by populations with autoimmune disease.

Public health relevance
PROJECT NARRATIVE The research proposed in this supplemental application builds upon our parent project to directly support NIH’s EXposome in Autoimmune Disease Collaborating Teams PLANning Awards (EXACT-PLAN) initiative. New activities will expand results that will improve characterization of the internal and external exposome in our study population. Findings will improve understanding of the impact of the environment on autoimmune disease and will help improve strategies for reducing the burden of autoimmune disease on population health.